Pharmacogenomic discovery of therapeutic targets for corrector-refractory cystic fibrosis

ABSTRACT
Chronic lung disease is the main cause of morbidity and mortality in cystic fibrosis (CF), a fatal
genetic disorder caused by mutations in CFTR, a Cl– ion channel in the plasma membrane (PM)
of the airway mucosa. Over 80% of people with CF (pwCF) have mutations that interfere with
folding of CFTR in the endoplasmic reticulum (ER), causing the ion channel to be triaged by
protein quality control (PQC) machinery and destroyed by the proteasome. Small-molecule
“correctors” that bind directly to and promote the folding of CFTR have become the standard of
care for people with ~180 CFTR variants, including the most common, F508del. Despite this
success, thousands of pwCF are not helped by the FDA-approved correctors, either because
they have ineligible variants that are unresponsive to the drugs, or they have eligible variants
that, for unknown reasons, are non-responsive. Moreover, correction is inefficient because
corrected CFTR variants that escape triage in the ER become substrates for PQC machinery in
post-ER compartments. The lack of effective mechanism-based therapies for thousands of
pwCF that do not respond to correctors is a critical unmet need demanding the development of
novel therapeutics. Development of new treatments is hampered by a profound gap in
knowledge of the cellular PQC machinery that promotes CFTR trafficking and degrades CFTR
in the ER and post-ER compartments. The proposed studies will exploit leading-edge
CRISPR-based pharmacogenomic analysis to fill this gap by identifying the PQC machinery that
underlies CFTR variant triage in the presence and absence of correctors. Specific Aim 1 will
use pooled genome-wide CRISPR analyses to comprehensively identify genes that govern the
stability of CFTR-F508del in ER and post-ER compartments and to dissect their epistatic
interactions with pharmacological CFTR correctors. Specific Aim 2 will modulate candidate
PQC targets in human airway epithelial cells from pwCF who carry the F508del variant. Specific
Aim 3 will leverage the methodology from Aims 1 and 2 to identify drug targets for
corrector-ineligible CFTR variants using CRISPR screens and CFTR functional assays in
patient-derived airway epithelia. The proposed studies will test the hypothesis that targeting
cellular PQC systems is an effective approach to CF management that is orthogonal and
complementary to existing and emerging CFTR modulators. Our findings are significant
because they will help advance new targets for treating corrector-resistant CF.

Public health relevance
Project Narrative Cystic fibrosis (CF) is a severe lung disease caused by loss-of-function mutations to the CFTR chloride ion channel. The aim of this proposal is to expand the number of people with CF who qualify for drug therapies that restore CFTR activity in the cell. We will use genome-wide functional genomics screens to identify drug targets that work through different mechanisms than the current FDA- approved corrector drug therapies and validate that modulating these targets rescue CFTR function in patient-derived airway epithelia.